CADRE Program for Postbaccalaureate Training in the Neurosciences

ABSTRACT
Despite the diversity of racial and ethnic groups in the US population, there is a marked lack of diversity
amongst research scientists. This is progressively more apparent moving further along stages of training and
of the profession, from undergraduate through graduate research to faculty. This is likely because in research,
as in many other professions, it is invaluable to have immersive early experience in the field to give individuals
the skills and self-confidence to succeed. Talented individuals without access to such experience are in effect
left out. We propose a comprehensive two-year post-baccalaureate (‘postbac’) program: Columbia Access to
Doctoral REadiness (CADRE) to address this lack of timely research experience. It is aimed at recent college
graduates of high potential who are interested in pursuing a research career in neuroscience but lacked
research opportunities as undergraduates. The core of CADRE is a two-year research project advised by
selected mentors within the Doctoral Program in Neurobiology and Behavior (NB&B) at Columbia University.
Postbacs will choose a lab from a range of neuroscience areas including behavioral and systems
neuroscience, cellular, molecular and developmental neuroscience, computational neuroscience, human
cognitive studies, and the neurobiology of neurological diseases. They will be supervised by engaged and
enthusiastic mentors chosen for their mentoring track record and skills, as well by a graduate student ‘buddy’ in
the lab. Importantly, the postbac will be fully integrated into the lab like other NB&B graduate students at the
same stage of training, attending lab meetings and journal clubs, discussing data and experimental design,
and participating in lab social life. This will give the postbac an immersive hands-on experience of starting a
research career. The postbac’s research project will also be complemented with coursework to strengthen their
academic foundations. In addition, throughout the program, postbacs will attend seminars, lectures, and other
educational events around Columbia University. In a step that is equally as important as the research
experience, postbacs engage in events that foster networking and professionalism. Activities will include: 1) a
professional development series addressing topics such as applying to research-focused graduate programs,
professional writing and presentation skills, maintaining work/life balance, and assessing mentorship styles; 2)
a career awareness series: “What you can be with a PhD?” 3) social and cultural activities around New York
City, and get-togethers with students; and 4) professional events during the academic year such as traveling to
two national scientific conferences, one in their first and one in their second year. We will evaluate the
effectiveness of the program with a starting, a midpoint and an exit survey through the course of the two-year
postbac. We will also gather long-term feedback from alumni.

Public health relevance
PROJECT NARRATIVE It is largely recognized that to best study and understand the health needs of a diverse population, it is important to have a diverse group of health scientists and researchers. However, many talented potential researchers fail to make it into biomedical research because they did not have access to adequate research opportunities in college. Here we propose a two-year post-baccalaureate program targeted at such individuals to help prepare them to enter and succeed in a biomedical research career.